HIV Vaccine Research and Development

The purpose of this interagency agreement between the United States Military HIV Research Program and the Division of AIDS, NIAID, NIH is to delineate and authorize implementation of a collaborative HIV/AIDS vaccine research and development program. USMHRP and NIAID remain committed to the common objective of developing a safe and effective vaccine for human immunodeficiency virus/acquired immune deficiency syndrome, HIV/AIDS.